The role of B cell estrogen signaling in menopause-associated metabolic dysfunction

ABSTRACT
Obesity is prevalent in women in the peri- and postmenopausal years. After menopause, women experience
greater risks of many diseases, including cardiovascular disease and type 2 diabetes (T2D). Estrogen (E2) loss
alters body composition by increasing and redistributing body fat, and decreasing energy expenditure and
metabolic flexibility. Together, these changes contribute to impaired whole-body metabolism. Adipose tissue
(AT) immune cell infiltration is a hallmark and driver of metabolic dysfunction during weight gain and obesity. B
cells express estrogen receptor alpha (ERα) and their role in initiating or promoting insulin resistance and weight
gain by cytokine and antibody secretion, modulating other immune cells, and promoting AT inflammation and
expansion is poorly understood. B cells accumulate in AT during weight gain and are required for obesity
development in male mice. When compared with immune-competent mice, B cell-deficient mice have reduced
weight gain and reduced fasting glucose levels after ovariectomy (OVX), a model of menopause. Recent findings
suggest that while E2 replacement after experimentally induced menopause prevents weight gain and improves
glucose metabolism, this effect is blunted in B cell ERα knockout mice. This finding demonstrates that B cell E2-
ERα signaling is a modulator of menopause-associated weight gain. The menopause-specific effects of estrogen
loss on B cell differentiation and trafficking into AT during peri and menopausal weight gain and with obesity are
not fully understood. Our overall hypothesis is that the loss of E2-ERα signaling in B cells contributes to post-
OVX weight gain by increasing proinflammatory cells and decreasing regulatory B cells in AT, ultimately resulting
in AT expansion, metabolic dysfunction, and low-grade systemic inflammation during induced perimenopause
and into menopause. We will use wild-type mice, B cell-deficient mice, and our B cell-specific ERα knockout
female mice to: 1) determine how the progressive decline of E2 alters B cell phenotype and infiltration into AT
during induced perimenopause and into menopause; 2) delineate B cell-mediated, E2-dependent effects on
weight gain in the aged milieu; and 3) define whether weight gain is attributable to B cells programmed to a
proinflammatory state by obesity or the loss of E2 signaling. These studies have the potential to uncover novel
immune regulators of AT expansion during menopause, metabolic dysfunction, and the subsequent risk of
developing age-related diseases.